Precision Medicine for Nutrition in EDEN

PROJECT ABSTRACT
Nutrition is an essential component in the care of critically ill patients with acute respiratory distress syndrome
(ARDS) who are often limited in volitional intake and who incur new deficits in physical function secondary to
their illness. Despite well-characterized associations between inadequate nutrition and adverse outcomes,
large multicenter trials of specific nutrition strategies have failed to consistently demonstrate clinical benefit
with any particular approach. The landmark NHLBI-funded Early versus Delayed Enteral Nutrition [EDEN] trial
investigated low-level (trophic) versus full enteral feeds in 1000 patients and demonstrated increased
gastrointestinal complications with full enteral feeds without any clinical benefit. Subsequently, current
guidelines recommend low-level feeds for all ARDS patients, however, ARDS is increasingly recognized as a
heterogeneous disease and a one-size-fits-all approach may not be appropriate. An essential first step in
individualizing nutrition in ARDS is identifying the clinical and biologic variables that contribute to heterogeneity
of treatment effect whereby individuals or groups vary in response to treatment. Thus, the overall goal of this
proposal is to characterize differential responses to nutrition by leveraging data and biospecimens from the
EDEN trial. In Aim 1, this proposal will investigate whether ARDS subphenotypes differed in response to low-
level versus full enteral nutrition in EDEN. Recent studies have identified two distinct ARDS subphenotypes
that differ in prognosis, host response, and potentially in response to treatments. ARDS subphenotypes have
not been investigated with regards to nutrition. Thus, Aim 1 will perform biologic assays to facilitate ARDS
subphenotype identification and will test for differences by subphenotype in clinical outcomes, in intestinal
permeability, and in incretin hormones. When released at physiologic levels in response to enteral nutrients,
incretins have beneficial effects on insulin release and glucose metabolism, but when released at
supraphysiologic levels in response to intestinal inflammation, incretins may worsen tolerance to nutrition by
reducing gastric motility. Incretins are not well characterized in ARDS. In Aim 2, this proposal will use
computational approaches that directly model individual treatment effects based on patient covariates allowing
for investigations of treatment response that result from a complex interaction between baseline demographics,
severity of illness, endocrine hormones, and inflammation at an individual patient level. Successful completion
of the proposed Aims will provide new knowledge on biologic responses to nutrition strategies, identify
mechanisms that contribute to heterogeneity of treatment effect at an individual level, and provide direction for
the next generation of precision nutrition studies in ARDS.

Public health relevance
PROJECT NARRATIVE Patients with acute respiratory distress syndrome often require artificial nutrition as part of their care, but questions remain about the optimal timing, level, route, and composition for the individual patient. Recent advances in precision medicine may help personalize delivery of nutrition if greater understanding of the clinical and biologic variables determining response to artificial nutrition is achieved. This proposal will perform biologic assays on existing biospecimens stored in the NHLBI Biologic Specimen Repository from one of the largest trials of nutrition in acute respiratory distress syndrome to help identify the variables influencing responses to one specific aspect of nutrition (level of nutrition) with the eventual goal of individualizing care.